Improving Anxiety Management and Rehabilitation Outcomes in Critical Care

DESCRIPTION (provided by applicant): The candidate's research interests encompass developing and evaluating patient-centered treatment approaches designed to facilitate engagement in rehabilitation therapies, in order to positively affect psychological and quality of life outcomes in adults surviving critical illness. Her short-term career goal is to conduct mentored research with guidance and expertise provided by leaders in the field of physical medicine and rehabilitation for critically ill and injured patients (Drs. Needham and Wegener). Her long-term career goal is to become an independent clinical researcher conducting patient-oriented research that is focused on developing, evaluating, and implementing psychological interventions to improve short- and long-term outcomes after critical illness. To reach this career goal, the candidate needs additional specialized training in several key areas to address important gaps in her training. Through mentorship, focused coursework in clinical research methods, grantsmanship workshops, and training in the ethical conduct of research, she will develop a solid foundation to build her career as an independent, patient-oriented clinical researcher. Formal training in advanced epidemiological methods, study design, and associated biostatistics will occur through didactic course work at the Johns Hopkins Bloomberg School of Public Health (JHSPH); an NIH-sponsored summer institute on Randomized Behavioral Clinical Trials; a 5-day intensive workshop on grant writing for rehabilitation research; attendance and presentations at annual scientific conferences; and attendance at the monthly Johns Hopkins Physical Medicine and Rehabilitation grand rounds. In addition, this learning will be reinforced and applied as part of regular mentoring meetings with Drs. Needham and Wegener who have relevant expertise and experience in clinical research methods in the candidate's field of study. The candidate will also have access to additional epidemiology and biostatistics faculty members who are part of Dr. Needham's Outcomes after Critical Illness and Surgery (OACIS) Research group. To improve anxiety management in critically ill patients participating in early rehabilitation therapies in the intensive care unit, the candidate plans to conduct a randomized controlled double-blinded pilot trial of a novel psychologist-administered intervention. The overall goal of this research is to improve the management of anxiety in critically ill patients participating in early rehabilitation therapies. Symptoms of anxiety, and current ICU anxiety management strategies, may be associated with worse psychological outcomes after hospital discharge. Evaluating the adverse effects of anxiety symptoms in the ICU, and the potential benefits of a novel anxiety management intervention is innovative and important for improving patient outcomes. The scientific disciplines and research areas encompassed by the proposed study will be multidisciplinary to include physical medicine and rehabilitation, rehabilitation psycholog, critical care and pulmonary medicine, physical therapy, occupational therapy, and nursing care specialties.

Public health relevance
PUBLIC HEALTH RELEVANCE: The number of survivors of critical illness is large and rapidly increasing due to the aging population, increasing intensive care unit (ICU) demand, and improving ICU mortality rates. Anxiety is a common psychological issue experienced by patients during and after intensive care. This research will create new knowledge regarding the impact of anxiety on patient recovery after critical illness and will evaluate the effect of a novel psychologist-administered anxiety treatment approach in the ICU on patients' engagement in rehabilitation while hospitalized, and on psychological recovery and quality of life after critical illness. __SpecificAimsTextDelimiter__ Specific Aims and Hypotheses Millions of patients are admitted annually to an intensive care unit (ICU) in the U.S., accounting for nearly $80 billion in hospital expenditures and 1% of the gross domestic product (1,2). The number of survivors of critical illness is large and rapidly increasing due to the aging population, increasing ICU demand, and improving ICU mortality rates (3-7). However, survival from critical illness comes at a substantial "cost" in terms of common and long-lasting neuropsychological and physical sequelae, and associated impairment in quality of life (7-22). Recent studies have demonstrated the importance of early physical rehabilitation in the ICU setting with benefits on survivors' physical function and length of stay (23-30). Psychological issues, such as negative affect (i.e., anxiety/neuroticism), have important adverse effects on engagement in rehabilitation therapies (31); although the impact of psychological issues on rehabilitation engagement has not been studied in the ICU setting. Anxiety is a particularly common psychological issue faced by ICU survivors. Between 23-48% of ICU survivors experience anxiety symptoms up to one year after ICU discharge (18,32-34). Anxiety has an adverse impact on post-ICU psychological function (e.g., post-traumatic stress disorder (PTSD)) (11,18,32) and health- related quality of life (4,11,12,32,33). In the ICU setting, symptoms of anxiety are commonly managed with short-acting anxiolytic medications (35,36) that have important unintended side effects, including ICU delirium (37), prolonged hospitalization (35,38), and anxiety symptoms after hospital discharge (39-41). Examining and treating psychological issues, such as anxiety, is a key research priority identified for the ICU patient population (1). The overall goal of this research is to improve the management of anxiety in critically ill patients. We hypothesize that management of anxiety in the ICU will be associated with improved engagement in rehabilitation therapies in the ICU and ward, reduced length of stay, and improved psychological and quality of life outcomes after hospital discharge. The target population for our study is alert and non-delirious critically ill patients who endorse symptoms of anxiety and have been prescribed rehabilitation therapies in a Medical ICU. The Specific Aims are as follows: Aim 1: To evaluate the impact of anxiety symptoms on engagement in rehabilitation therapy and length of stay in hospital, and on psychological and quality of life outcomes at 3 months after hospital discharge. Hypothesis 1: Anxiety symptoms in critically ill patients are associated with reduced engagement in rehabilitation therapies, longer length of stay, and adverse psychological outcomes (e.g. symptoms of anxiety, PTSD, and depression) and impaired quality of life at 3 months after hospital discharge. Aim 2: To conduct a randomized controlled double-blinded pilot trial of a novel, psychologist- administered, anxiety management intervention in the target population. Hypothesis: Participants randomized to intervention vs. control groups will experience the following benefits: Hypothesis 2A: in the ICU and hospital, reduced anxiety, greater engagement in rehabilitation therapies, and shorter length of stay; and Hypothesis 2B: at 3 months after hospital discharge, reduced adverse psychological outcomes (e.g. symptoms of anxiety, PTSD, depression) and better quality of life. Successfully engaging in physical rehabilitation early during critical illness recently has been demonstrated to enhance physical function and reduce healthcare utilization (23-30). However, physical rehabilitation may be impeded by anxiety. Symptoms of anxiety, and current ICU anxiety management strategies, may be associated with worse psychological outcomes after hospital discharge. Evaluating the adverse effects of anxiety symptoms in the ICU, and the potential benefits of a novel anxiety management intervention is innovative and important for improving patient outcomes and reducing healthcare utilization. The proposed research is a key research priority identified for this target population, and will form an essential and timely foundation for addressing the growing public health problem of psychological and physical impairment after critical illness (1).